RANDOMIZED COMPARATIVE TRIAL OF TWO DOSES OF DDI IN SYMPTOMATIC HIV INFECTION

This study evaluates the efficacy, safety and tolerance of two dose levels of dideoxyinosine in HIV infected children who are either unresponsive to zidovudine or intolerant to zidovudine.